Reactive Oxygen Species in the Initiation, Survival and Racial Disparity of Uterine Leiomyoma

To date, we do not understand why there is such a high prevalence of uterine leiomyoma in premenopausal
women nor do we understand the reasons for the racial disparity observed in this disease. Black women tend
to develop tumors earlier and are more numerous, larger in size and more symptomatic than other ethnic
groups. We have studied the molecular mechanisms involved in leiomyoma tumor growth and survival as it
pertains to hormones and signaling pathways and found that reactive oxygen species (ROS) plays a significant
role in leiomyoma pathogenesis. Moreover, for the first time, we discovered that ROS levels and effects on
DNA are increased in the myometrial and leiomyoma tissues of Black compared to White women. We
hypothesize that ROS promotes mutations in the MED12 gene, to promote leiomyoma tumor formation. In
addition, ROS promotes growth and survival of the leiomyoma tumors as estrogen and progesterone provide a
homeostatic environment to protect the tumors from the toxicity of high ROS levels. We propose mechanistic
and molecular analyses to test our hypothesis including mutational analysis upon chronic treatment with ROS,
analysis of ER and PR occupancy on chromatin in response to ROS, and we test the BCL2 inhibitors to target
cells where ROS promotes senescence when estrogen and progesterone are absent. In all of our studies, we
will compare the tissues from Black versus white women which will generate valuable and novel insight into
the racial disparity observed in leiomyoma. We will learn about early changes that may lead to leiomyoma
development as well as provide biological rationale to treat leiomyoma tumors with the BCL2 inhibitors.
Project Summary/Abstract

Public health relevance
Uterine leiomyomas occur in approximately 77% of all women in the United States and can cause severe morbidity and infertility, particularly in Black women. In this proposal, we will study the importance of reactive oxygen species (ROS) on initiating leiomyoma tumor development as well as studying how sex hormones, estrogen and progesterone allow the growth of leiomyoma tumors despite the toxic effects of ROS. With this knowledge, we can specifically target this pathway with existing drugs that will clear leiomyoma cells that are under ROS stress.